CTSA Predoctoral T32 at University of Minnesota

ABSTRACT
The mission of the Clinical and Translational Science Institute (CTSI) predoctoral T32 Program is to contribute
to the nation’s biomedical workforce by training a diverse pool of scientists in clinical and translational science
(CTS) and leadership. We will meet this mission by developing, implementing, and continually improving a
training program for predoctoral trainees (Scholars) that integrates a mentored research experience with an
individualized curriculum combined with professional development activities highlighting our institutional
strengths in community engagement, data science, team science, and effective communication skills. The
UMN CTSI T32 Program is built upon our current successful Translational Research and Career Development
(TRACT) TL1 program, which guided the development of early-stage CTS researchers over the past 4 years.
Through personalized mentorship, coursework, seminars, and other tools, the TRACT program has guided 18
predoctoral Scholars along a rigorous path of professional development in CTS. Moving forward, the new UMN
CTSI T32 Program’s mission is to educate and train a diverse group of Scholars from across the UMN system
in the fundamentals of CTS through a 2-year comprehensive yet individualized program that complements their
education and training in their interdisciplinary doctoral programs. We will recruit and train 3 cohorts (diverse in
discipline and underrepresented populations) of 8 predoctoral Scholars from across UMN. The UMN CTSI T32
will provide a research experience with mentors trained in evidence-based mentoring and collaboration with
community members throughout the research process, inclusive of a Community Mentor and team science
across the UMN ecosystem. The UMN CTSI T32 will also include near-peer learning experiences with other
CTSI program Scholars, as well as provide education and opportunities for a variety of career paths. The UMN
CTSI T32 will use a comprehensive and adaptive evaluation plan for rigorous programmatic assessment and
continuous quality improvement to maximize the training experience. The principal Scholar outcome is to have
a deep knowledge in the science of translation beyond translational research. Another key Scholar outcome is
an understanding of the importance of, and key strategies for, building truly collaborative interdisciplinary
teams composed of people from diverse backgrounds and experiences whose collective roles synergistically
optimize the advancement of diagnostics, therapeutics, clinical interventions, and behavioral modifications that
improve health. Other outcome measures include the ability to communicate and engage with other scientists
and nonscientific audiences and collaborators through our intensive formalized training in communicating
science and community engagement (i.e., the Community Mentor Program). Programmatic outcomes include
the development of training modules and workshops on the most effective community engagement and
communications strategies exportable to the national CTSA consortium.

Public health relevance
UMN Predoctoral T32 Narrative The Clinical and Translational Science Institute (CTSI) predoctoral program trains the next generation of scientists to speed application of scientific discoveries to improve human health. Scholars will participate in 2 years of mentored research, individualized curriculum, and professional development activities highlighting our institutional strengths in leadership, community engagement, data science, team science and effective communication skills.